Compensatory mechanisms that promote homologous recombination in BRCA1 mutant cancers

PROJECT SUMMARY The BRCA1 protein functions in homologous recombination (HR), a DNA repair process that uses the undamaged sister chromatid to carry out high fidelity repair of DNA double strand breaks (DSBs). Genetic knockout of HR genes in mice demonstrated that Brca1 and the process of HR are critical for viability. In contrast, loss of the BRCA1 wild-type allele provides a growth advantage and cells are positively selected during cancer initiation in patients with germline BRCA1 mutations. In our preliminary analyses, we show that the BRCA1 mutant allele is invariably retained in cancers derived from patients with germline mutations. Interestingly, Brca1 mutant alleles have been shown to prolong embryonic viability in Brca1 null backgrounds, suggesting partial rescue of full-length Brca1 activity. In our recently published studies, we show that BRCA1 mutant alleles are capable of generating truncated proteins and promote residual HR in BRCA1 mutant cancers. In this proposal, we will investigate the importance of BRCA1 mutant alleles and HR for cell and tumor viability in BRCA1 mutant cancers. Furthermore, cells that are deficient in HR DNA repair, such as those lacking functional BRCA1 or BRCA2, are highly sensitive to platinum and PARP inhibition (PARPi). However, emerging data indicate that PARPi therapy may benefit only a subset of BRCA1 mutation carriers. In the second part of this proposal, we will uncover mechanisms that elevate HR to a level required for platinum and PARPi resistance. We show that proteins generated from BRCA1185delAG and BRCA1C61G alleles fail to interact with BARD1, lack ubiquitin ligase activity, and are only capable of providing moderate platinum and PARPi resistance. We hypothesize that BRCA1-BARD1 ubiquitin ligase activity is important for more robust levels of HR that is necessary for therapy resistance. In preliminary data, we identified RNF7 and RNF207 as novel ubiquitin regulators that demonstrated increased expression in PARPi resistant BRCA1185delAG and BRCA1C61G clones, and compensate for ubiquitin ligase deficient-BRCA1 proteins. We will manipulate the expression of ubiquitin ligase proteins and measure DNA repair, PARPi and cisplatin sensitivity in vitro and in vivo. Proteins that contribute to resistance will be assessed for expression in PDX models as well as primary tumors. Using these approaches, we will address the following Specific Aims: 1) investigate the role of BRCA1 mutant alleles in maintaining HR and cancer viability; and 2) investigate HR-promoting mechanisms contributing to therapy resistance. Our work will ultimately contribute to the development of biomarkers that predict therapy response and reveal novel targets for chemo- sensitization.

Public health relevance
PROJECT NARRATIVE There are approximately 55,000 deaths from breast and ovarian cancer annually in the United States, with BRCA1 and BRCA2 mutations found in 5-7% of breast and 6-15% of ovarian cancer cases. Platinum-based and PARP inhibitor therapies exploit DNA repair defects and extend the lives of BRCA1/2 mutation carrying patients; however, drug resistance invariably emerges and chemotherapy-resistant disease is the primary cause of death. The goal of this project is to understand the role of homologous recombination DNA repair in BRCA1 mutant cancers and therapy resistance.